Uncovering the molecular function of novel transposon-encoded Cas9 homologs

PROJECT SUMMARY
Mobile genetic elements (MGEs) possess the ability to mobilize within genomes and/or between
genomes from distinct species, and are a major driving force in the spread of antibiotic resistance and virulence
genes. Due to the unrelenting assault of MGEs, prokaryotic organisms have evolved numerous sophisticated
defense systems that operate on both an innate and adaptive level, and in some cases directly target MGE
nucleic acids in a sequence-specific manner. Of notable importance in recent years are immune systems
encoded by clustered regularly interspaced short palindromic repeats (CRISPR) and CRISPR-associated (Cas)
genes, which employ guide RNAs for the targeted binding and cleavage of foreign nucleic acids.
Remarkably, Cas genes themselves have evolved from genes encoded within MGEs, and transposons
in particular. A striking example is the RNA-guided DNA endonuclease, Cas9, which evolved directly from a
distinct group of homologous transposon-encoded proteins within the TnpB family (and is hereafter referred to
as Cas9H), whose molecular functions are entirely unknown. Beyond these initial bioinformatic observations,
my recent analyses have uncovered a conserved non-coding RNA (ncRNA) that shows strong genetic
association with Cas9H genes. I hypothesize that ancient, transposon-encoded Cas9 homologs function
together with guide-like RNAs, to modulate the excision, efficiency, and/or target site specificity during
transposition of the mobile element. By discovering this primordial biological function, my work will offer
insights into the evolutionary trajectory of CRISPR-Cas9 and uncover core enzymatic properties that nature used
as starting material to arrive at a potent and highly programmable RNA-guided DNA endonuclease.
In Aim 1, I will bioinformatically identify transposable elements containing Cas9 homologs to prioritize
candidates for experimental study, and develop a robust heterologous expression system to monitor
transposition events. Importantly by monitoring genome-wide insertion specificity will inform whether Cas9H
modulates target selection. In Aim 2, I will elucidate the function of the non-coding ‘HEARO’ RNA through
systematic mutagenesis, and determine the role of Cas9H nuclease domains in transposition. Finally, in Aim 3,
I will adopt a biochemical approach to directly probe protein-RNA interactions between Cas9H and the ncRNA,
and uncover the role of its conserved nuclease domains, laying a foundation for future structural studies that
may shed light on ancient scaffolds conserved between TnpB and Cas9. This project will leverage my training
as a molecular geneticist and expand my abilities in bioinformatics and biochemistry. These experiments will be
the first to rigorously probe the function of a TnpB family protein, and reveal for the first time how TnpB/Cas9H
modulates transposition. In addition to providing insights into the evolutionary origins of CRISPR-Cas immune
systems, completion of this work will also inform the development of new genetic engineering tools.

Public health relevance
PROJECT NARRATIVE CRISPR-Cas9 and Cas12 exploit guide RNAs for the targeted cleavage of foreign nucleic acids during an antiviral immune response, yet enigmatically, both enzymes descend from a class of transposon-encoded proteins — TnpB — of unknown function. The proposed project aims to elucidate the role of TnpB in transposition, by specifically interrogating the significance of its nuclease domains and non-coding RNA substrates. Our results will reveal the trajectory of molecular domestication that led to the evolution of CRISPR- Cas adaptive immunity, much like recent insights into the origins of RAG1/2 for vertebrate adaptive immunity, and may uncover new genetic tools for targeted transposition.